Development of an Integrated Dental Plaque Bioanalytical Platform for Point-of-Care Diagnostics of Oral Diseases

ABSTRACT
Dental caries poses a significant financial burden to the oral healthcare system in the US. Hence, early detection
and preventive measures for primary caries are essential for reducing treatment costs. It is well-established that
biofilm metabolic activity (lactic acid production) in the oral cavity, particularly close to the teeth, plays a pivotal
role in the progression of dental caries, and hydrogen peroxide (H2O2) has been identified as a crucial factor in
controlling lactic acid producing bacteria. We therefore propose to develop a quantitative and easy-to-read
electrochemical biosensing platform that will use live dental plaque samples for potential point-of-care
diagnostics to test the following hypothesis: Can the capacity of dental plaque to produce metabolites—such as
H2O2, associated with oral health, and lactic acid, linked to caries development—be used to establish threshold
values for the early detection of caries?
AIM 1: Detect and quantify hydrogen peroxide and lactate produced by varying ratios of the bacterial species S.
sanguinis (Ss) and S. mutans (Sm). Our innovative electrochemical sensors will be used along with microliter
volume droplet hydrogel electrochemical cells, which can trap and analyze the picomoles of metabolites (H2O2
and lactate) produced by different ratios of beneficial bacteria (Ss) and pathogenic bacteria (Sm).
AIM 2: Establish a correlation between oral caries conditions and untreated dental plaque metabolic activity. We
will establish the correlation between the ratio of H2O2 to lactate produced by dental plaque from patients and
determine the threshold value that distinguishes non-caries from early caries conditions. We will also investigate
the time-dependent metabolic activity of dental plaque in the presence of various sugars such as glucose and
sucrose to gain insights into the cariogenic potential of dental plaque samples.
Our analytical platform will eliminate the need for sample pretreatment, separation, or preconcentration and thus
will enable the rapid and accurate analysis of metabolites produced by dental plaque. This study will validate
dental plaque as a noninvasive bio-sample for point-of-care diagnostics in oral health, paving the way for early
detection of dental caries and personalized prevention plans. The need for invasive treatments will thereby be
reduced, ultimately lowering healthcare costs.

Public health relevance
Project Narrative Dental caries, a preventable disease, poses a major issue in oral health, costing billions of dollars annually, prompting the need for an early caries diagnostics tool. The proposed innovative analytical platform combines a unique hydrogel and electrochemical sensing to quantify minuscule amounts of metabolites by using untreated dental plaque samples, enabling the early detection of caries risk and thus contributing to the NIH's aim of advancing human health through fundamental research.